SAFETY &EFFICACY OF NUTROPIN TO IMPROVE WELL BEING AFTER GH TREATMENT

The purpose of this study is to determine if Nutropin growth hormone improves body composition, physical strength and endurance, feelings of well-being and produce positive changes in various laboratory tests.